The Diabetes Clinical outcomes Associated with Retention and Engagement in Care, in Samoa (Diabetes CARE)

Project Summary
This proposal presents a five-year research career development award for Dr. Anna Rivara, an Associate
Research Scientist (Yale's equivalent to Assistant Professor (Research)) in the Department of Chronic Disease
Epidemiology at the Yale School of Public Health (YSPH). The proposal aims to address important issues
surrounding the current epidemic of Type 2 Diabetes Mellitus (T2D) being experienced by Samoans and other
Pacific Islanders. Project goals are to 1) examine preferences for diabetes care among adult Samoans recently
diagnosed with diabetes using a discrete choice experiment, 2) prospectively estimate the associations
between diabetes care and glycemic outcomes among adult Samoans, and 3) longitudinally assess diabetes
care decision-making and coping strategies. Outcomes from this project will be integral to understanding and
offering effective and acceptable treatment options to alleviate the burden of diabetes faced by Pacific Islander
populations. The proposal describes a rigorous, mixed methods-based investigation that will be made possible
through the advanced mentoring and training that the PI will receive throughout the award period. The
proposed work will be conducted under primary mentors Dr. Nicola Hawley, Ph.D, Associate Professor of
Epidemiology (Chronic Diseases) at YSPH, Dr. Leslie Curry, Ph.D., MPH, Professor of Health Policy at YSPH
and Associate Director of the Yale Scholars in Implementation Science Training Program, and Dr. Satupaitea
Viali, MBBS, MPH, of the National University of Samoa and the University of Otago. Additionally, collaborators
Dr. Omar Galárraga, Ph.D, Associate Professor of Health Services, Policy and Practice at Brown University
School of Public Health, Dr. Rochelle Rosen, Ph.D., Associate Professor of Behavioral and Social Sciences at
The Miriam Hospital and Brown University, Dr. Erin Kershaw, Ph.D., MD., Associate Professor of Medicine at
the University of Pittsburgh, and Dr. Jenna Carlson, Assistant Professor of Biostatistics and Human Genetics
at the University of Pittsburgh, will be providing mentorship and hands-on training in research implementation,
dissemination, and mixed methods analyses. Dr. Rivara's training goals are to 1) gain new skills in discrete
choice experiments and longitudinal analytical approaches and advance skills in mixed methods data collection
and mixed effects linear modeling; 2) strengthen professional development through preparation and
submission of policy briefs and peer-reviewed manuscripts and science communication via presentation of
results at invited seminars, and national and international conferences; and 3) advance skills in grantsmanship
though didactic and applied training and the construction and submission of a diabetes-focused R01
intervention upon the completion of the award period. Together, the research outcomes and training will lay the
foundations for Dr. Rivara's career developing culturally sensitive, participant-guided interventions in low
resource settings as a diabetes-focused health services researcher.

Public health relevance
Project Narrative The goals of this project are to 1) examine preferences for diabetes care among adult Samoans recently diagnosed with diabetes using a discrete choice experiment, 2) prospectively estimate the associations between diabetes care and glycemic outcomes among adult Samoans, and 3) longitudinally assess diabetes care decision-making and coping strategies. The project will use the tools and methodologies of health economics, longitudinal quantitative and qualitative approaches, and implementation science to comprehensively assess diabetes care experiences and provide formative data necessary to build evidence- based, patient centered and sustainable diabetes interventions and treatment programs